Multiscale Modeling of Influenza Neutralizing Antibody and Fc Effector Biology

Seasonable inlfuenza A and B result in up to 500,000 deaths globally each year, and influenza pandemics
resulting form antigenic shifts have the potential to result in in orders of magnitude higher mortality. However,
seasonable influenza vaccines are only 10-60% effective, and are unlikely to provide any protection against
novel pandemic strains. To address these challenges, our long-term vision is to develop computational models
that predict the sequences of antibody archetypes generated in response to an influenza protein sequence, and
then predict via simulation ensembles the protection afforded by a polyclonal response — with obvious and direct
application to mRNA and other vaccines. Our short-term goal for this proposal is to construct generative models
of the antibody repertoire and mechanistic models to investigate how a polyclonal antibody response protects
against infection. Here, our overarching hypothesis is that eliciting a diverse but coordinated humoral immune
response will result in more effective and robust vaccines. To understand how a pluralistic humoral immune
response, with diverse neutralizing and effector antibody mixtures, is generated and coordinated to protect
against the influenza virus, computational modeling is essential. Hence, we propose to develop multiscale
computational models calibrated on extensive infection and vaccination datasets. These computational models
will guide vaccine development by providing the tools to generate anti-influenza antibody sequence candidates,
identify effective defense mechanisms at the airway mucosa, and predict vaccination outcomes in heterogenous
populations. In Aim 1, we propose to develop protein language models (PLM) to capture antibody repertoire
information from BCR-seq and Ig-seq data sets as high-dimensional vectors in an embedding space, using
samples from healthy, infected, and vaccinated human cohorts. By comparative analysis of the distribution
of antibodies in the embedding space, we will identify sequence archetypes of the anti-influenza response, and
experimentally characterize the biophysical and functional properties of synthetic archetypal antibodies. In Aim
2, we propose to develop agent-based models (ABM) to capture the spatiotemporal CODEX data sets of
parenchymal cells, immune cells, antibodies, and virus from ex vivo experiments in lung explants from
human donors. These models will enable in silico simulations to evaluate hypotheses for how innate and
humoral mechanisms provide protection at the mucosal interface. In Aim 3, we propose to develop dynamical
systems models to capture nonlinear interactions between the effector functions of a polyclonal antibody
response and the impact on peak viral load and clearance time from qualified clinical immunoassays from
human influenza challenge cohort data sets. The overall impact will be delivery of three complimentary
antibody, agent-based, and compartmental computational platforms that together will rapidly accelerate the
genesis of broadly effective seasonal and universal influenza vaccines.

Public health relevance
There is a significant gap in our scientific understanding of how antibodies protect against severe influenza infection. This project will develop computational models to understand antibody diversity, function, and coordination at the molecular, tissue, and individual scales from an extensive collection of human datasets. By providing in silico platforms for generating antibody repertoires, modeling mucosal defense, and simulating infection outcomes, these models will rapidly accelerate the development of more effective influenza vaccines.